Admin Core - WA LHS E-STAR

ADMINISTRATIVE CORE – SUMMARY
The Washington Learning Health System Embedded Scientist Training and Research Center (LHS E-STAR
Center) brings together a multidisciplinary team to train a diverse LHS workforce in CER/PCOR methods and
the LHS core competencies; strengthen partnerships with research institutions, primary care organizations,
community partners, and other stakeholders; and conduct patient-centered comparative effectiveness research
projects to improve health system operations and quintuple aim outcomes of health equity, clinician well-being,
better health for patients, improved population health, and lower costs. The Administrative Core is the
leadership, operations, communications, and evaluation hub for the E-STAR Center, providing mechanisms
and procedures for all Cores to collaborate effectively to train scholars, complete research projects, and
maintain focus on meaningful, productive partnerships. We build on our past success in training a diverse set
of LHS scholars to become independent scientists through our K12 LHS training program (CATALyST) and on
decades of experience training organizations in primary care quality improvement and providing technical
assistance to primary care organizations, including at Federally Qualified Health Centers (FQHCs). This LHS
E-STAR Center is focused on primary care transformation and will build infrastructure and capacity for primary
care organizations, including four diverse FQHCs, to accelerate progress towards becoming integrated
learning organizations. Led by Principal Investigator Lozano, and supported by Associate Director and Co-
investigator Allen, Co-investigator Cole, the Admin Core includes an active and engaged Steering Committee
that serves as a multistakeholder primary leadership team, an Advisory Board who provides methods and
content expertise and connections to disseminating organizations, a center administrative team comprised of
leaders from each of the Center Cores, a project manager, and administrative support. The Administrative
Core will address three specific aims: (1) Provide leadership and governance to maximize learning and impact,
(2) Foster partnership and engagement of E-STAR Cores, partner organizations, LHS scholars, mentors,
patients and community members, and (3) Evaluate and iteratively Improve the E-STAR Center program and
activities. We will accomplish these goals by managing and coordinating interactions and information flow
across partners and stakeholders; creating a supportive and inclusive learning environment for our E-STAR
community of scholars, mentors, FQHCs, patients, integrated health systems, and other stakeholders;
monitoring and evaluating Center activities; and disseminating resources and tools developed through the E-
STAR Center to practice and research communities. Our formative and summative evaluation plan and defined
metrics ensure attentive tracking systems are in place to iteratively improve our program and processes, and to
demonstrate progress and impact for health systems and the communities they serve.

Public health relevance
Project Narrative not required for this component.